Health Education and Reproductive Health

Project Summary.
Compared to heterosexual women, sexual minority women (e.g., lesbian and bisexual women) face
heightened risk for sexual and reproductive health (SRH) disparities. Though this seems counterintuitive, many
sexual minority women have sexual histories with men which place them at risk for outcomes like teenage
pregnancy. Research has shown that sexual minority women are also less likely to use contraceptive methods
including barrier-based protection that can prevent sexually transmitted infections (STIs), and they have higher
rates of STI contraction than heterosexual women. To date, the health communication mechanisms that
contribute to these disparities are not well understood. Wider literature on general female populations points to
sexual health information, patient-provider communication, and maternal communication as important
predictors of SRH in adolescent and adult female samples. However, exploratory descriptive work on the
health information and communication experiences of sexual minority women point to themes of difficulty
accessing appropriate information, negative or uninformative encounters with providers, and hesitation from
mothers about discussing SRH with sexual minority girls. Thus, the goal of this project is to examine how
sexual health information, patient-provider communication, and maternal SRH communication differ by sexual
orientation and mediate SRH disparities in a sample of women from across the United States. These data,
which are derived from three ongoing cohort studies of adolescent health, provide a unique opportunity to
examine detailed measures of sexual orientation, health communication, and SRH histories of a large
population-based sample of U.S. women. These research goals will be facilitated by the applicant’s training
plan, which involves advancement in skillsets of biostatistics, epidemiology, and health communication
research methods. Combined with a collaboration team of experts in the disciplines of social epidemiology,
sexual minority health, biostatistics, and health communication, all of whom are hosted within the Boston
Children’s Hospital network, this fellowship will provide an exceptional training environment and mentorship
experience in these subject areas and contribute greatly to the success of this research plan. Findings from
this project will be innovative in their ability to address communication facilitators and barriers of SRH in sexual
minority women, a population that has been understudied in the wider SRH and health communication
literature base. Findings will also be significant in their translation to both the sexual health information and
communication practices of medical providers and other sources of health information (like maternal SRH
communication). Ultimately, this NRSA addresses an important and vulnerable health area for sexual minority
women, a group recently recognized by the NIH as a health disparity population.

Public health relevance
Project Narrative. Sexual minority women are more likely than heterosexual women to experience negative sexual and reproductive (SRH) outcomes. The goal of this project is to examine how sexual orientation differences in SRH information and communication mediate SRH disparities in a large, longitudinal sample of U.S. women.